Exercise, MANF, and Chemical-Induced Neurodegeneration

Project Summary
Exercise dramatically improves multiple facets of human health, but the molecular mechanisms by which
exercise confers health benefits are not well understood. Known systemic benefits from exercise include
substantial neuroprotection; for example, physical exercise is the sole intervention that improves patient
outcomes and slows progression of Parkinson’s Disease. The mechanism for neuronal improvement is
unclear, but an intriguing possibility is that protection is mediated through modulation of secreted proteins
called neurotrophic factors. For example, recent studies have reported increased mesencephalic astrocyte-
derived neurotrophic factor (MANF) levels after exercise. MANF is normally stored in the endoplasmic
reticulum (ER), and is released upon conditions of ER stress. MANF specifically protects dopaminergic
neurons, but the mechanisms by which MANF is protective, and the specific role of exercise in this process,
are not well understood. Interestingly, MANF interacts with mitochondrial proteins, and mitochondrial content
and activity are increased by exercise, raising the possibility that MANF mediates exercise-induced
mitochondrial robustness. Understanding cellular and organism-wide mechanisms operating to confer benefits
from exercise is essential for informing exercise recommendations for neurodegenerative disease and risk
assessment for neurotoxicants.
This Pathway to Independence career development award will experimentally test the relationship between
physical exercise, the neurotrophic factor MANF, and chemical toxicant-induced neurodegeneration in the
versatile model organism Caenorhabditis elegans. This model is especially appropriate for this question
because MANF is the only neurotrophic factor conserved in nematodes, and my preliminary data shows
swimming exercise in C. elegans concomitantly improves mitochondrial health and increases MANF
expression. I hypothesize that exercise conditioning decreases neurodegeneration by protecting from
chemical exposure-induced ER stress and mitochondrial dysfunction, and that this protection is
mediated through the neurotrophic factor MANF. To test this hypothesis, I will subject wild-type, MANF-
deficient, and MANF-overexpressing nematodes to exercise conditioning and/or neurotoxicant (rotenone and
6-hydroxydopamine) exposures. I will then determine the impact of MANF status on toxicant response by
assessing ER stress, mitochondrial dysfunction, and neurodegeneration in the three MANF genetic
backgrounds via the following aims: Aim 1. Assess role of MANF in exercise-induced physiological changes;
Aim 2. Identify role of MANF in systemic crosstalk between ER stress and mitochondrial dysfunction after
toxicant exposure; Aim 3. Determine impact of exercise and MANF on toxicant-induced neurodegeneration.
Overall, knowledge gained from this study will establish a model for long-term mechanistic dissection of
exercise benefits in the context of both toxicant exposure and diseases of aging.

Public health relevance
Project Narrative Physical exercise is the sole intervention that improves patient outcomes and slows progression of Parkinson’s Disease, but the cellular mechanisms underlying those improvements are not well understood. Knowledge of the mechanisms by which exercise is neuroprotective will improve human health by giving new targets for therapeutic intervention and informing risk assessment for environmental exposures. This proposed research will examine the role of the neurotrophic factor MANF (mesencephalic astrocyte-derived neurotrophic factor) in mediating exercise protections from chemical exposure-induced mitochondrial dysfunction, endoplasmic reticulum stress, and neurodegeneration.